Burn induces hypermetabolism via browning of the white adipose tissue

Project Summary/Abstract
Despite the widely-recognized importance and complexity of the post-burn hypermetabolic response, the
underlying mechanisms by which a thermal injury induces and sustains hypermetabolism for years after the
injury are essentially unknown. Recently, adipose tissue has been recognized as an essential player in the
induction and persistence of hypermetabolism after burn injury. Like cold stress, burn injury induces the
browning of white adipose tissue (WAT), in which subcutaneous WAT converts to a more brown-like adipose
termed beige/brite adipose tissue (BAT). These otherwise quiescent beige cells adopt brown-like features,
including multilocular lipid droplets and high UCP1 expression. Moreover, browning drives a conversion in
mitochondrial function, uncoupling the respiratory chain from ATP synthesis and predominantly producing heat,
thereby sending these already hypermetabolic patients into metabolic overdrive. While browning can have
beneficial effects in patients with obesity and diabetes, we believe that browning in burn patients fuels high
metabolic rates and alters plasma lipid profiles, leading to accelerated development and progression of
cachexia, hyperglycemia, and organ steatosis thereby worsening outcomes of severely burned patients. The
overarching hypothesis of this proposal is that browning of the adipose tissue is a central process in the
pathologic hypermetabolic response, and one of the main mediators of persistent hypermetabolism after burn.
This hypothesis will be systematically tested using a series of murine knock outs in our established burn
model. The aim of this proposal is to study the mediators, function, consequences and potential treatments of
the browning response after burn. The four specific aims (SA’s) are, firstly, to determine the consequences of
browning on outcomes after burn (SA 1). Next, we will determine the metabolic and physiologic consequences
of browning after burn (SA 2). We will proceed to determine central mediators by which a burn induces
browning and hypermetabolism (SA 3) before proceeding to uncover whether therapeutic targeting of browning
can improve outcomes after burn (SA 4). In summary, to date, the cellular and molecular mechanisms
underlying the post-burn hypermetabolic response have not been identified, and despite improved clinical care,
the detrimental sequelae of this response lead to a substantial post-burn morbidity and mortality. In this
proposal we will explore the mechanism of induction of beige adipose post-burn, the signals leading from
adipose to hypermetabolism, catabolism and dysfunction of various organs, and explore targeted disruptions in
these cascades in order to develop specific therapeutics to improve outcomes. Our work will be carried out
with a systematic series of murine knock-outs using a validated burn model. This project has value from a
basic science standpoint and is highly relevant for patient outcomes.

Public health relevance
Project Narrative Although hypermetabolism after burn is a well-documented phenomenon that is associated with poor outcomes, the underlying mechanisms are essentially unknown. We have recently shown that browning of the white adipose tissue (WAT) occurs after burn and that browning contributes to profound metabolic alterations. The studies proposed herein will elucidate the mechanisms behind the browning of WAT, a phenomenon contributing to the augmented and persistent hypermetabolism in burn patients, allowing for the development and implementation of improved treatment options post-burn.